RHINOVIRAL CHALLENGE ON BIOAVAILABILITY AND TOLERANCE OF INHALED INSULIN

Currently injections are the only method to deliver insulin. Pfizer Inc. and Inhale Therapeutic Systems have developed a dry powder insulin formulation and aerosol delivery device that safely delivers a rapid acting insulin by forming a cloud that patients can draw into their lungs where the insulin is absorbed. Since inflammation can reduce the tolerance and bioavailability of inhaled medications, this study will measure changes in tolerance and bioavailability of inhaled insulin during rhinoviral infection. Potential patients are being screened for study. Study expected to be completed early in 1998. Recruitment complete.